Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
Building on an established administrative organization and management plan that has been effective in
implementing the goals of the Maine INBRE, the Administrative Core will engage all ME-INBRE institutions to
stimulate institutional development and research and training in comparative functional genomics. To that end
the Administrative Core will provide scientific leadership, administrative and fiscal oversight, and logistical
support to the network. The Principal Investigator (PI) has primary responsibility for administering the program
and overseeing the development of the INBRE. He is assisted in this by the Program Coordinator (PC) and a
Program Administrator (PA), with financial oversight provided by the Director of Finance and Sponsored
Programs Manager. Decisions regarding overall direction and all activities of the INBRE, budgets, and core
usage are made by the PI and PC with advice from the Core Directors, the Steering Committee, and the
External Advisory Committee. Steering Committee members serve as liaisons between the PI and network
institutions, and ensure implementation of programmatic activities and procedures at their institutions. The
Administrative Core will manage the Developmental Research Project Program and work coordinately with the
Bioinformatics Core and Research Training and Resources Core to implement programs to meet the research
training, career development, mentoring, and infrastructure needs of faculty, students, and institutions in the
network. Infrastructure needs are identified and addressed in consultation with the Steering Committee. The
Administrative Core will work with the Research Training and Resources Core to coordinate networking,
sharing of resources, and collaborations with Maine COBREs, the Northern New England CTR, and other
INBREs. The Administrative Core will implement an evaluation strategy that will assess and guide Maine
INBRE's progress in strengthening Maine's biomedical research capacity and competitiveness. The evaluation
plan includes rigorous formative and summative assessment that will determine the effectiveness of INBRE
activities. To provide an independent evaluation of the INBRE, an external evaluation will be conducted by the
External Advisory Committee and by a second, independent, external evaluation panel. Finally, the
Administrative Core will engage in strategic outreach activities with the private sector to develop partnerships
that create opportunities for student internships and employment, and thus develop a continuous pipeline from
early training into careers within the state of Maine that will enhance biomedical research infrastructure and
economics across Maine and in the Northeast Region.